Automated lab identification and sorting (Rapid-IDX) for mosquito surveillance

Overview. The proposed work will advance state of the art mosquito surveillance technology through
development of an automated species identification and sorting system, Rapid-IDX. The proposal builds
on Phase I results, during which the mechanical subcomponents for isolation, separation, and
transportation, multi-angle optics system, and prototype algorithm were designed and validated. For phase
II, the optics and mechanical systems designed will be integrated into functional prototypes for a
minimum viable product (MVP), an image database will be developed to focus algorithm development on
key medically-relevant mosquito species, and iterative functionality and usability testing will be
conducted with potential customers.
Intellectual Merit. Rapid-IDX will allow for rapid data generation of high-resolution, multi-angle images
of mosquito specimens for training of Convolutional Neural Networks (CNNs) for identification; the large
and robust dataset enabled with this technology will help push Vectech’s technology towards more
nuanced and powerful algorithms. This phase II work centered on StarAttGAN represents the state of the
art with regard to generative models for dataset augmentation. These developments will enable addressing
a critical issue in computer vision: that of sampling bias in vast noisy, fine-grained, openset multiclass
classification problems.
Broader Impacts. The proposed work supports United States critical public health infrastructure and
public health literacy in the face of growing incidence of vector borne disease as a result of climate
change, globalization, and other factors. The system will provide Vector control organizations (VCOs),
which protect local communities in the US from disease-carrying insects, with more robust capacity in
vector surveillance data gathering, a critical component of integrated vector management. Additionally,
US Armed Forces face a significant threat of vector-borne diseases around the world, making the
Department of Defense one of the largest customers for vector surveillance and control products. We are
seeing emerging competitors in the pest information space in Germany, Israel, China, and South Korea
(see commercialization plan). Investment in Vectech ensures there’s an American company to compete in
the global market. We will collaborate with leading US-based MCOs for development and optimization of
this product, ensuring product-market fit. Furthermore, the technical team leading this phase II proposal
represents several underrepresented groups in STEM, including women, BIPOC, and the LGBTQ
community.

Public health relevance
Project Narrative. The goal of this project is to develop the first automated lab identification and sorting (Rapid-IDX) system to expand mosquito vector surveillance capacity while reducing operational costs. Accurate and timely mosquito species identification is a critical but highly resource intensive environmental health activity. Leveraging our expertise in computer vision and optics, we seek to develop a practical system that will increase global biosurveillance capacity and capability.